Task V7: Clinical and NHP Sample Testing for SARS-CoV-2 Biological Product Candidates

The Evaluation and Testing Services (ETS) for Vaccines and Other Biologics for Infectious Diseases contract provides a variety of product development services from early feasibility studies through activities required for the submission of Biologic License Application (BLA) and/or Investigational New Drug (IND) applications. These services will facilitate the development and introduction of new biologics (regulated by CBER) against potential agents of bioterrorism and emerging and re-emerging infectious diseases.